Core A: Administrative Core

Project Summary
For reasons unknown, Texas has one of the highest incidence rates of kidney cancer in the US. UT Southwestern
Medical Center (UTSW), together with its affiliates, the county hospital, Parkland Memorial Hospital (staffed by
UTSW faculty), and Texas Health Resources, cares for 57% of all new kidney cancer patients in the Dallas-Fort
Worth metroplex. At UTSW Simmons Comprehensive Cancer Center (SCCC), kidney cancer is the 5th most
common tumor type. In 2013, the Kidney Cancer Program (KCP) was inaugurated. Recognized with a Leaders
in Clinical Excellence Program Award and a finalist for the metroplex Innovation in Healthcare Award, the KCP
has been a trailblazer. Directed by Dr. Brugarolas, and with the goal to promote collaborative, interdisciplinary
research to translate discovery and technical innovation at UTSW, the KCP provides a foundation for the
UTSW Kidney SPORE and serves as a vehicle for its integration within UTSW/SCCC. As the coordinating hub
of the SPORE, the Administrative Core provides essential administrative services and organizational support to
the SPORE as a whole. The Director of the Core, Dr. Brugarolas, will continue to provide overall direction and
scientific leadership, promote multidisciplinary interactions, and oversee fiscal management and reporting. His
scientific background, experience across the research continuum and administrative roles enable him to serve
as an effective overall SPORE PI and Director of the Administrative Core. Dr. Kapur, Co-Leader of the KCP and
previously SPORE PI successor, has been promoted to SPORE PI and Core A Co-Director. Dr. Conacci-Sorrell,
an underrepresented minority and Co-Leader of the CEP, will also be joining the Administrative Core as Co-
Director. An Executive Committee comprised of representatives from all Projects and Cores provides advice on
SPORE strategic directions, departmental and administrative interactions, faculty recruitment, and resource
allocation. A Patient Advocacy team representing the spectrum of the cancer experience (from current patients
to cancer survivors and caregivers) is actively engaged in leading community and educational events,
fundraising, and perhaps most inspiringly, volunteering at SCCC clinics to assist other patients. An Internal
Advisory Board made up of institutional leaders serves as a sounding board, and an External Advisory Board
of leaders in their fields with complementary expertise assists by evaluating progress and providing input on
future directions. The KCP/SPORE benefits from a strong commitment from both UTSW and the SCCC with
each committing $200,000 yearly to promote kidney cancer research, thereby extending the reach of the CEP
and DRP programs, as well as $1,100,000 in recruitment funds. Core A will continue to fulfill its objectives through
the following Aims. Aim 1: Partnering with the SCCC and UTSW to advance a program of excellence in kidney
cancer. Aim 2: Serving and engaging the kidney cancer patient population. Aim 3: Furthering a state-of-the-art
translational kidney cancer research program. Aim 4: Recruiting investigators through successful Developmental
Research and Career Enhancement Programs. Aim 5: Supporting and leading national initiatives.